Novel ctDNA biomarker for androgen therapy in metastatic prostate cancer

PROJECT SUMMARY
The deadliest form of advanced-stage prostate cancer is treatment-resistant metastatic castration-
resistant prostate cancer (mCRPC), which occurs in ~35% of patients after exposure to androgen
receptor (AR)-directed therapies such as Abiraterone and Enzalutamide, resulting in a dismal median
survival of only ~5.5 months. Unfortunately, detection of treatment-resistant disease typically occurs
too late, when patients are already progressing on AR-directed drugs, after which they succumb rapidly
to their disease. There is therefore a critical need to detect AR resistance more sensitively and earlier
in the disease course. To address this, our team designed a novel cell-free DNA assay called Enhancer
and Neighboring Loci of Androgen Receptor Sequencing (EnhanceAR-Seq), built upon the Cancer
Personalized Profiling by deep Sequencing (CAPP-Seq) platform, and demonstrated superb sensitivity
for detecting AR gene body and enhancer locus alterations in plasma collected from mCRPC patients.
Notably, we applied our EnhanceAR-Seq technology to mCRPC patient plasma and showed that the
results correlate strongly with clinically verified resistance to AR-directed therapy, and significantly
outperform circulating tumor cell (CTC) AR-V7 detection. Building upon this, the current proposal will
evaluate whether our EnhanceAR-Seq technology can be used to predict both (Aim 1) pre-treatment
and (Aim 2) on-treatment resistance to AR-directed therapy in mCRPC patients. Further, in Aim 3 we
will investigate whether integrating EnhanceAR-Seq with genome-wide methylation sequencing can
granularly refine our ability to predict treatment resistance and monitor both clonal and phenotypic
evolution in mCRPC. We are uniquely positioned to accomplish this through our interdisciplinary team
comprised of cell-free DNA genomicists, bioinformaticians, oncologists, and statisticians. Overall, this
study has significant translational impact by establishing cell-free genomic and epigenomic biomarkers
of tumor evolution and resistance to AR-directed therapy in men with lethal prostate cancer.

Public health relevance
PROJECT NARRATIVE Treatment-resistant metastatic castration-resistant prostate cancer (mCRPC) is the deadliest form of prostate cancer, with a dismal median survival of only ~5.5 months. Unfortunately, by the time this deadly form of disease is diagnosed, patients are already progressing on androgen receptor (AR)- directed drugs and prognosis is very poor. We developed a liquid biopsy biomarker, referred to as EnhanceAR-Seq, to more sensitively detect resistance early with the longer-term goal of advancing personalized treatment strategies to improve patient outcomes and survival.